Administrative and Bioinformatics Core

The Administrative Core (Core A) will direct and coordinate several major areas contributing to the activities of the Development of Rectal Enema as Microbicide (DREAM) Program whose overall goal it is to develop a single dose tenofovir prodrug enema to provide one week of protection from HIV infection following unprotected receptive anal intercourse. These activities include (1) administrative oversight of the entire program including all Projects and Cores, (2) providing financial oversight of the program, (3) act as primary liaison with the NIAID/DAIDS appointed Program Officer with responsibility for the Integrated Preclinical/Clinical Program for HIV Microbicides and Biomedical Prevention U19 Program, (4) coordinate the monthly conference calls for the Steering Committee (SC) and disseminate agendas / meeting minutes in a timely fashion, (5) organize the annual IP/CP meeting, (5) in collaboration with NIAID/DAIDS, establish and provide logistical support for a Scientific Advisory Panel facilitation, and (6) undertake website maintenance, education, publication assistance, library maintenance, and general administrative support. The Core will link the various project leaders and programs as well as integrate the related milestones of each project and ensuring communication between project leaders. The SC, composed of the Principal Investigator and each Project Leader/Associate-Leader, Core Leader/Associate Leader, and select key personnel, will be the central mechanism in assuring communication between Projects, Project sites, and Cores. The Administrative Core will also produce twice-yearly internal progress reports for the SC. These will be available to interested key personnel and the NIH's Scientific Advisory Panel (SAP).

Public health relevance
The DREAM Program plans development of a single dose tenofovir enema to protect from rectal HIV infection. The Administrative Core will be the primary mechanism to provide administrative, logistical, and financial support for the DREAM Projects and Cores as they pursue their milestones.